Minocycline Plus N-Acetylcysteine Improves Brain Structure and Function After Experimental Brain Injury with Clinically Useful Time Windows

Therapeutic time window is a key element of any drug to treat TBI. Patients with moderate to severe TBI can be
treated hours after injury;; those with mild TBI may delay treatment for days until their symptoms do not abate.
Few drugs have been developed with therapeutic time windows long enough to treat TBI, in part, because little
is known about which cellular functions can be targeted by drugs dosed hours to days post-­injury (PI). The
combination of minocycline (MINO) plus N-­acetylcysteine (NAC) retains high potency when first dosed 12h PI
(MN12). Published and preliminary data suggest that MN12 prevents neuronal loss and protects dendrites in the
hippocampal ipsilateral to the impact site, allows learning of an active place avoidance task that requires both
hippocampi;; and restores late long-­term potentiation (LTP) to both hippocampi. Preliminary data suggests that
a first dose of MINO plus NAC at 72H PI (MN72) is less potent than MN12 yet restores acquisition of Barnes
maze, a task that requires only one hippocampus, and late LTP in the hippocampus contralateral to the impact
site. MN72 also increases protein synthesis in the contralateral hippocampus. This proposal examines if MN12
and MN72 target dendrites, synapses, spines, and synaptic protein synthesis after closed head injury (CHI) in
mice. Proposed studies will examine whether MN12 and MN72 target protein kinase M zeta (PKMz), which is
essential for late LTP and retention of hippocampal-­dependent tasks. Studies will also examine whether MINO
plus NAC remains potent when dosed later than 72H PI. These data support 3 specific aims (SA) that test a
central hypothesis that: Dosing of MINO plus NAC at clinically relevant therapeutic time windows limits
gray matter injury and improves cognition and memory. SA1: Where does a first dose of MINO plus NAC
at 12 or 72h after CHI repair dendrites, spines and synapses? The working hypothesis of SA1 is that MN12
acts bilaterally to prevent injury and induce repair while MN72 acts only on the contralateral hippocampus. SA1
will also assay neuroinflammation, oxidative stress and mitochondrial morphology after MN12 or MN72
treatment. SA2: Does MN12 and MN72 target PKMz expression to restore synaptic plasticity and
acquisition of hippocampal-­dependent tasks? SA2 will examine a role for PKMz expression by MN12 or
MN72 using NTSA, a novel and specific inhibitor of PKMz, or in conditional PKMz mutant mice. SA2 is predicted
to show that MN12 or MN72 target PKMz to restore late LTP and long-­term memory. SA 3: Does MINO plus
NAC limits brain injury and restore function in the subacute (14D PI) or chronic (45D PI) stages of TBI?
The utility of MINO plus NAC would be greatly increased if the drugs retained potency when dosed in later
phases of TBI. These studies have high potential significance since they show that a combination of FDA-­
approved drugs with clinically useful windows can restore cognition and memory, which are central deficits
produced by TBI. These studies have potentially high impact since the absence of effective drugs make people
with TBI less likely to seek treatment. MN12 and MN72 are attractive candidates for clinical trials to treat TBI.

Public health relevance
Drugs developed to treat traumatic brain injury typically lose potency when first dosed many hours to days after injury. As a result, we know little about which brain functions can be improved with drugs at time windows when patients are typically treated for their head injuries. This proposal examines how a combination of two FDA- approved drugs, minocycline and N- acetylcysteine, restores proper connections between nerve cells and improves learning and memory when first dosed either 12 or 72 hours after experimental traumatic brain injury.